Structure and Regulatory Mechanisms of the Vacuolar ATPase

Project Summary
Our laboratory has a long standing interest in understanding the catalytic and regulatory mechanism of
the proton pumping vacuolar ATPase (V-ATPase, V1Vo-ATPase), a dynamic multisubunit membrane integral
rotary motor enzyme found in all eukaryotic cells. The V-ATPase acidifies the lumen of organelles and, in
professional acid secreting cells, the extracellular space. Enzyme function is required for fundamental cellular
processes such as endocytosis, bone remodeling, protein trafficking, acid-base balance, sperm maturation,
and neurotransmitter release. While complete loss of V-ATPase function is embryonic lethal, partial loss or
hyperactivity is associated with numerous human diseases such as osteopetrosis, diabetes, male infertility,
neurodegeneration, and cancer. Moreover, some viruses such as influenza rely on the acidic environment
created by the V-ATPase for infection. Fighting these diseases on a molecular level will require a detailed
understanding of the structure, catalytic mechanism and regulation of the eukaryotic V-ATPase. In cells, V-
ATPase activity is regulated by a unique mechanism referred to as “reversible disassembly”, wherein the
complex reversibly dissociates into V1-ATPase and Vo proton channel, with both sub-complexes becoming
autoinhibited. Despite its important role in V-ATPase physiology, the molecular mechanism of reversible
disassembly is poorly understood. This gap in knowledge is largely due to a lack of both high-resolution
structural information and an in vitro model system to study the process under defined conditions, aspects that
we are working to address. An interesting, and technically challenging feature of the mammalian V-ATPase is
that most of its subunits are expressed as multiple isoforms. However, as such isoforms display differential
tissue enrichment, they may provide opportunities for targeted therapeutics. Indeed, several diseases have
been linked to malfunction or upregulation of specific isoform containing V-ATPase. However, how different
isoform combinations determine tissue localization, and whether these isoform specific complexes have unique
biochemical or regulatory properties, is currently unknown. We have started to develop a system to purify wild
type and mutant forms of human V-ATPase in an isoform specific fashion for biochemical and structural
analyses. Further, we are developing single-domain antibodies (Nanobodies) against specific subunit isoforms
to serve as research tools, and to explore isoform specific modulation of V-ATPase activity in disease. Our
research program employs the tools of structural biology, cell biology, biochemistry and biophysics to address
broad questions of V-ATPase catalytic and regulatory mechanisms. For some fundamental aspects of V-
ATPase structure and regulation, we study the enzyme from yeast, a well documented model system for the
human V-ATPase. We use human tissue culture for questions that cannot be addressed in yeast, such as
structure and biochemical properties of specific isoform containing enzymes. The long term goal of our
research is to find ways to modulate the activity of disease causing V-ATPases in an isoform specific way.

Public health relevance
Project Narrative The proton-pumping vacuolar ATPase (V-ATPase; V1Vo-ATPase) is a multisubunit enzyme complex that is responsible for vital cellular functions in all eukaryotic organisms and which is linked to several devastating human diseases such as renal tubular acidosis, osteopetrosis, diabetes, neurodegeneration, cancer, and microbial and viral infections. This proposal requests funds for obtaining high-resolution structural information for active holo V-ATPase and its autoinhibited proton channel subcomplex in lipid nanodiscs to study inhibitor binding and for elucidating V-ATPase's unique mode of regulation, for elucidating biochemical properties of specific isoform containing human V-ATPase, and to develop single-domain antibodies directed against yeast and human V-ATPase subunit isoforms as a novel tool for studying V-ATPase's structure and regulatory mechanisms. The long-term goal of the project is to gain a molecular understanding of the enzyme's role in human disease, and to identify novel ways to modulate the activity of disease causing V-ATPase in a subunit isoform and tissue specific manner.